Leadership and Administration Core

The overarching objective of the Leadership and Administrative Core (LAC) is to advance the scientific
knowledge base of multifactorial geriatric conditions. The LAC, which is led by two board-certified geriatric
physician investigators with complementary expertise, is responsible for strategic planning, organization,
administrative operations and evaluation of the OAIC research and training program. A special effort is devoted
to ensure the cohesion of the Center and maintenance of an interdisciplinary and translational research focus
on the common research theme, which is "the investigation of multifactorial geriatric conditions". The key LAC
tasks are achieved by the Core Leader (Dr. Thomas Gill), Co-Leader (Dr. Terri Fried), Associate Leader, two
Administrators, and three committees: the Executive Committee, the Internal Advisory Committee, and the
External Advisory Committee. The LAC has gained much experience, knowledge, and understanding of OAIC
operations over its 25 years of continuous funding, including the past 15 years under the P30 mechanism. We
will build on the strong existing collaborative relationships and cumulative expertise as we enter our next
funding cycle.
The Specific Aims of the LAC are to: (1) oversee the coordination, integration, and administration of all
aspects of the OAIC, including the utilization of core resources, and foster collaborations with other research
and training programs that will help to accomplish the OAIC goals; (2) promote the conduct of academically
productive, innovative, high impact, and clinically safe research by Pepper Scholars, other early-stage
investigators, Pilot/Exploratory Studies (PESs), Resource Cores, and External Projects; (3) ensure the
independent review and oversight of OAIC research and the training of Pepper Scholars and other early-stage
investigators; (4) foster the career development of junior faculty/other trainees from multiple disciplines into
independent investigators and academic leaders in aging research; (5) recruit and encourage outstanding
early-stage investigators and senior faculty to focus their research on aging, particularly multifactorial geriatric
conditions, with an emphasis on translation between basic and clinical research; (6) identify and facilitate
productive collaborations with other OAICs and institutions; and (7) monitor university, government and fiscal
matters, ensure the preparation of necessary progress reports and administrative documents relating to the
award, and collaborate with the NIA project office and Coordinating Center on OAIC activities.
Taken together, the LAC provides support for planning, organizational, evaluation, and administrative activities
relating to the other Cores and to the OAIC as a whole. The LAC is responsible for monitoring, stimulating,
sustaining, evaluating, and reporting progress toward the overall goals of the Yale OAIC.